Mechanisms mediating podocyte-parietal epithelial cell crosstalk in proliferative glomerulopathies

To date, approximately 30 million Americans are estimated to have chronic kidney disease, a major
health care burden in the United States. Podocytes are terminally differentiated post-mitotic visceral epithelial
cells in the glomerulus whose major function is the maintenance of the renal filtration barrier. Glomerular
diseases such as Rapidly Progressive Glomerulonephritis (RPGN) and subtypes of Focal Segmental
Glomerulosclerosis (FSGS), in particular collapsing and cellular variants, are marked by initial podocyte injury
and detachment, which triggers aberrant proliferation of neighboring parietal epithelial cell (PEC), resulting in
crescent or pseudocrescent formation and eventual glomerulosclerosis. Previous studies suggest the crosstalk
between podocytes and parietal epithelial cells (PECs) might play a role in the pathogenesis of these
hyperplastic lesions, but the mechanisms remain unclear. Activation of Signal Transducer and Activator of
Transcription 3 (STAT3) has been implicated in the initiation and progression of both RPGN and collapsing
FSGS. Although activation of STAT3 signaling plays an important role in the pathogenesis of RPGN and
subtypes of FSGS, the regulation of STAT3 signaling remains to be explored. Recent studies demonstrate that
a zinc-finger transcription factor, Krüppel-Like Factor 4 (KLF4), might serve as a key negative regulator of
STAT3 signaling. Although several members of the KLF family have been implicated in cell differentiation,
KLF4 was first identified as a critical negative regulator of proliferation. Our preliminary data suggests that the
podocyte-specific loss of Klf4 in mice renders the activation of dysregulated glomerular STAT3 signaling,
podocyte injury, PEC proliferation, and eventual FSGS and renal failure. Furthermore, we showed that the
activation of STAT3 signaling inversely correlated with KLF4 expression in the glomeruli of kidney biopsies with
RPGN as compared to control specimens. Based on these data, we hypothesize that podocyte-specific KLF4
is required for the maintenance of podocyte integrity and prevention of aberrant PEC proliferation in
proliferative glomerulopathies. We propose to test this hypothesis through the following specific aims: (1)
Investigate the requisite role of podocyte-specific KLF4-STAT3 signaling in proliferative glomerulopathies and
(2) Determine the central mechanisms mediating podocyte-PEC crosstalk in proliferative glomerulopathies.
This research proposal aims to address a current gap in the field by elucidating the mechanisms by which
podocyte loss triggers aberrant proliferation in the PECs in proliferative glomerulopathies. The long-term goal
of our project is to identify dysregulated pathways inducing PEC proliferation that might serve as “druggable”
targets in the development and/or progression of proliferative glomerulopathies.

Public health relevance
Chronic Kidney Disease is predominantly a result of initial injury to the glomerulus, the filtration system in the kidney. Dysregulated signaling between injured visceral and parietal epithelial cells is a major contributor to glomerular dysfunction and eventual kidney failure. In this research proposal, we aim to investigate the mechanisms mediating this cellular crosstalk in glomerular disease.